Chicago CCFC for the new AsA-NHPI cohort

PROJECT SUMMARY/ABSTRACT
The University of Chicago (UChicago) Center for Asian Health Equity (CAHE) and the Institute for Population
and Precision Health (IPPH) put forth this plan to leverage decades of experience enrolling underrepresented
minorities, and especially Asian Americans, into health studies and epidemiologic cohorts as a
clinic/community field site for the new NIH-funded AsA-NHPI Cohort (NAC). We plan to enroll 2,500
participants from communities in the metropolitan Chicago area with large Asian subgroup representation
using a population-based sampling framework. We will specifically target South Asian, Korean, Filipino and
Southeast Asians (Cambodian, Vietnamese, and Laotian) in randomized census tracts using a 2-stage
sampling design. Our long-term partner, the Asian Health Coalition (AHC) has been serving as the national
engagement lead for the All of Us Research Program and has set the national model for community engaged
cohorts tailored to Asian inclusion. We have identified active community partners who are already supporting
enrollment into a similar protocol. In this proposal, the UChicago MPIs and team enthusiastically propose a
collaborative approach to meet the RFA milestones; building on prior success and experience working on
national multisite cohorts with an emphasis on racial diversity, scientific rigor, and innovative approaches to
improve health disparities. We suggest an approach and methods for consideration for the common protocol
during the UG3 period, with full appreciation for the balance of decisions that will need to be made to ensure
efficient recruitment, comprehensive yet not burdensome surveys, thoughtful clinical protocols that can be
implemented in a community or in-home setting, and high-quality biospecimens processed and banked to
support scientific investigation and ancillary studies. We plan to hire bilingual, bicultural individuals from the
Asian community and train them to work as “community ambassadors (CAs)” during the entire study period, a
model that has proven highly effective in Asian communities previously, promoting both participation and
retention. We have an institutional commitment to deploy mobile medical units (MMUs) and study vans to
targeted study areas at no cost to the grant to ensure that we can lower barriers to participation. We are
confident that our proposed approach will allow us to meet the cohort UG3 and UH3 milestones, short-, mid-
and long-term goals, and contribute significantly to this important effort in all phases.

Public health relevance
PROJECT NARRATIVE The University of Chicago (UChicago) Center for Asian Health Equity (CAHE) and the Institute for Population and Precision Health (IPPH) put forth the Chicago AsA-NHPI Cohort CCFS to leverage decades of experience enrolling underrepresented minorities, especially Asian Americans, into health studies and epidemiologic cohorts as a clinic/community field site for the new NIH-funded AsA-NHPI Cohort (NAC). We plan to enroll 2,500 participants from communities in the metropolitan Chicago area with large Asian subgroup representation using a population-based sampling framework. Our long-term partner, the Asian Health Coalition (AHC) has been serving as the national engagement lead for the All of Us Research Program and has set the model for community engaged cohorts tailored to Asian inclusion. In this proposal, the UChicago MPIs and team enthusiastically propose a collaborative approach to meet the milestones; building on prior success and experience working on local, regional and national multisite cohorts with an emphasis on racial diversity, scientific rigor, and innovative approaches to improve health disparities.